Applied Research

PROJECT SUMMARY: APPLIED RESEARCH COMPONENT
The Squirrel Monkey Breeding and Research Resource (SMBRR), P40 OD010938 has received
continuous NIH grant support since 1980. The SMBRR’s proposed applied research component will include
projects that will broaden the application and usefulness of the resource for the user community, as well as
provide information that will allow for better management of the colony itself. The proposed behavioral
phenotyping project is designed to increase the available squirrel monkeys pretrained on an automated
cognitive testing system (ACTS). These monkeys can then be used by SBMRR users in a variety of research
programs that use operant responding or assess cognitive functions as a primary outcome measure in the
disease model. Additionally, the use of the ACTS within or breeding colony will allow for assessment of
health status and impending parturition. Studies in the applied component will also examine the impact of
iron supplementation on reproductive outcome as a means of decreasing fetal wastage. Finally, studies in the
applied component will also measure the impact of xylazine administration on brain, behavior and cognition
in the squirrel monkeys. Xylazine is common anesthetic with nonhuman primates including with squirrel
monkeys within the SMBRR. Recent studies have shown the xylazine has significant abuse liability and can
have acute and long-term impacts on behavioral and brain function. We will compare age-sex matched
squirrel monkey cohorts receive either xylazine alone, xylazine + ketamine or a vehicle on their cognitive,
neurological morphology and functional connectivity. These outcome data will help inform management and
veterinarian care practices on the use of xylazine as an anesthetic in this species.